Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Washington University NORC Administrative Core promotes collaboration, growth and success within the
NORC membership. The NORC Director, Associate Directors, Administrator, and Core Directors/Associate
Directors, with governance by the Executive Committee, are responsible for monitoring and documenting the
use of each Core, preventing overlap of funding for services provided, managing the budget, and making
certain compliance and appropriate guidelines are met. The Administrative Core oversees the Enrichment
Program, manages the Pilot and Feasibility Program, coordinates the Executive Committee and External
Advisory Committee meetings, tracks publications and grants that were facilitated by NORC funding, manages
and oversees the fiscal aspects of the NORC and reports annually to the NIH/NIDDK.